Research Education Component

Project Summary: Research Education Component
The OADRC Research Education Component (REC) will provide a crucible for securing and advancing the
needed research workforce into the future, continuing the OADRC's strong history of fostering the development
of gifted researchers, facilitated by unique resources, faculty and programs for education and training. The
REC provides a unique opportunity to bring together, in a comprehensive and concerted way, faculty,
educational programs and experience for early-stage researchers to ultimately produce research of the highest
quality. The primary objective guiding this REC is to prepare skilled scientists for a successful career in
Alzheimer's and related dementias (ADRD) research. Consistent with the NIH Alzheimer's Disease Centers
Panel Recommendations and in accordance with RFA-AG-24-001, we seek to recruit early-stage scientists into
the ADRD research field, provide them with a well-rounded educational experience, and instill in them a
passion for this work. Our REC will be attuned to providing a Personalized Research Education Component
Inspiring Science Excellence-- a “PRECISE”, customized program that will serve each scholar throughout their
career. We will provide training opportunities to enrich and deepen their understanding of dementia and equip
them with superb skills in writing, analysis and the conduct of translational science, and include mentoring in
scientific design and implementation, professional comportment, and early faculty adaptation.
With this background and context in mind, the OADRC REC's four Specific Aims are to:
1. Provide a tailored educational program utilizing didactic, experiential and individualized mentored
opportunities (lectures, seminars, courses, one-on-one coaching, responsible conduct of research, real-
life laboratory and clinical activities) that cover a range of important skills and proficiencies: knowledge
of foundational reference content for the field, ethical conduct of research, culturally relevant research,
good research habits and practice, research design and methodology, grant and manuscript writing,
presentation skills, collaboration and data sharing, and leadership acumen.
2. Establish a strong cadre of engaged and transdisciplinary senior faculty to support and mentor diverse
early-stage scientists and/or scientists new to ADRD research.
3. Identify and engage early career scholars with an emphasis on recruiting junior faculty as REC program
scholars with a strong focus on involving those under-represented in ADRD research, with the goal of
training and sustaining new leaders in ADRD research.
4. Carefully and iteratively evaluate the progress and refine the delivery of the REC program's educational
structure, processes, and outcomes.